Endothelial lineage specification and differentiation in vertebrate embryos

DESCRIPTION (provided by applicant): Recent advances in cell culture studies provide invaluable insights on how the endothelial lineage is modulated by diverse signaling pathways. However, the cellular and molecular mechanisms that regulate the initial specification of endothelial lineage within developing embryos are largely unknown. To delineate the developmental origin of the endothelial lineage, we previously generated a laser assisted single-cell resolution fate map in the most ventral region of zebrafish gastrula that provided the first detailed distribution pattern of the hemangioblast, a hypothetical common precursor for both endothelial and hematopoietic lineages. Additionally, in our previous study, we found that hemangioblasts only produce a subset of the endothelial lineage, while the majority originates from endothelial specific progenitors, indicating the heterogeneous developmental origin of endothelial lineage. Our recent observation that avascular mutant embryos recover from their initial lack of endothelial cells later in development, further supports this idea, and suggests that the progenitors of the endothelial lineage consist of spatially and temporally distinct subpopulations. In this proposal, by using a multifaceted approach, we plan to delineate the heterogeneity of endothelial progenitors, and elucidate how distinct subpopulations of endothelial progenitors respond differently to Wnt signaling, which, based on our preliminary data, appears to be a key modulator of endothelial lineage specification. Three specific aims are designed to achieve these goals. First, we will expand our single-cell resolution fate map analyses to test whether hemangioblasts exist in other areas of the gastrula. This approach will also determine the embryo-wide distribution patterns of progenitors with endothelial potential, and will allow us to identify subpopulations of endothelial progenitors with distinct developmental potentials. In the second aim, we plan to define the cellular origin of endothelial cells involved in the vascular recovery of avascular mutant embryos. The analyses on two of previously isolated avascular zebrafish mutants will identify subpopulations of progenitors that generate endothelial lineages in a temporally distinctive manner. Lastly, we will examine whether subpopulations of endothelial progenitors respond differently to Wnt signaling by using transgenic lines that are capable of manipulating the time and place of Wnt activity. Understanding the developmental heterogeneity of the endothelial lineage will provide invaluable insights on how endothelial lineage is established during development. In addition, the proposed research will enhance our knowledge on how distinct cell types emerge from pluripotent progenitors during development. Furthermore, the proposed research may provide essential groundwork for the therapeutic application of pluripotent progenitors with the ability to ameliorate clinical conditions affecting the circulatory system in humans.

Public health relevance
PUBLIC HEALTH RELEVANCE. The proposed research aims to understand how endothelial cells emerge during development from progenitors. Information acquired from the proposed research will enhance our current knowledge on the mechanisms that regulate the differentiation of pluripotent progenitors (for example, stem cells) into specific cell types. Furthermore, it will also help us to understand the etiology of many vascular diseases and design a better way of using pluripotent progenitors for the therapeutic purposes.